BETA SUBUNITS ROLE DURING POTASSIUM CURRENT MATURATION

The goal of this study is to identify auxiliary channel subunits that influence potassium current maturation and consequent shortening of the action potential duration in Xenopus spinal cord neurons. Knowledge regarding the molecular identities of the specific channel subunits evoking these developmental changes is incomplete. Voltage-dependent potassium channels are believed to be oligomeric proteins comprised of four membrane-spanning alpha subunits which together form the ion-conducting pore. In addition, auxiliary beta subunits associate with the complex. beta subunits modulate potassium current activity in several heterologous systems. Recently, Xenopus beta subunit clones have been obtained. They are expressed in developing spinal cord neurons. Therefore, they may influence potassium current maturation. To address this possibility, we will first examine the endogenous levels and distribution of beta subunit RNA and then investigate the effects of overexpressing beta subunit genes on whole cell potassium currents during development. These experiments should elucidate how beta subunits contribute to potassium current activity in developing Xenopus spinal cord neurons. The goal of the proposed experiments is significant, because the functional role of beta subunits in situ during development has not yet been defined. Ultimately, such knowledge will provide a more complete understanding of the development of neuronal excitability. Such information may lead to the design of more effective therapies to treat disorders of the developing nervous system or disorders due to inappropriate excitation such as epilepsy.